Development of New Technologies at Roswell Park to Further Cancer-Based Research and Treatment Through Genome Modification

Abstract
The current application seeks salary support for Aimee Stablewski, PhD who serves as the Director of the
Gene Targeting and Transgenic Shared Resource (GeTT) of Roswell Park Comprehensive Cancer Center
(Roswell Park). This position was created in 1999 to oversee the research applications of the various genome
editing platforms available in the resource and to apply her extensive experience in these areas in
collaborations and consultations with the GeTT investigator user base. With over 25 years of experience in
research applications of the creation of genetically modified animals and cells (23 years at Roswell Park), Dr.
Stablewski throughout her career has collaborated with many investigators at the Cancer Center on NIH
funded projects. The GeTT is an integral part of Roswell Park's Cancer Center Support grant (P30CA016056)
for which the cancer center Director, Dr. Johnson, serves as the Principal Investigator. All three CCSG
programs (Developmental Therapeutics (DT), Tumor Immunology and Immunotherapy (TII) and Cancer Stress
Biology (CSB) equally make up the user base of the GeTT; and numerous NIH-funded researchers in these
programs actively collaborate and consult with Dr. Stablewski. Dr. Stablewski' s contributions to Roswell Parks
research enterprise have been significant and impactful specifically with regards to the NIH-funded research of
the members of the TII program. As of September 2022, there are thirty-nine grant applications that cited use
of the GeTT shared resources. There were twenty-six NIH/ NCI, two DOD, and the remaining applications
include private and public funding sponsors, eleven of whom were TII Program members, fourteen are CSB
members and nine are DT members.
The cancer center has also made significant investments in the GeTT with regards to advancing technology in
genetic modifications. With the changes in the R50 program now making the distinction between Laboratory
(PAR-20-288) and Core (PAR-20-287) based scientists and with the GeTT being an integral part of the
Roswell Park CCSG infrastructure, Dr. Johnson as the PI of the CCSG grant, will now serve as the Unit
Director for the application.

Public health relevance
Project Narrative The Gene Targeting and Transgenic Shared Resource is an integral part of the Roswell Park Comprehensive Cancer Center (Roswell Park) Cancer Center Support Grant (CCSG) program (P30CA016056, PI Johnson). As the Director of the Gene Targeting and Transgenic Shared Resource with over 25 years of relevant experience, Dr. Stablewski's efforts are solely dedicated to supporting all 4 CCSG research programs with regards to keeping abreast of current genome editing technologies for the creation of genetically modified tools (animal models and cell lines). Funding of Dr. Stablewski as NCI Core-based Research Specialist will ensure the stability of an essential resource to Roswell Park's CCSG program.